Deciphering the role of sex hormones in host-microbiome interactions in the human oral mucosa

Project Summary
The human body houses many distinct, but interconnected microbial populations which can exert long-lasting
systemic effects. Understanding how microbial communities interact with the host and how these interactions
influence host physiology is critical to defining their roles in health and disease states. In particular, the oral
microbiota serves as a reservoir for opportunistic pathogens, potentially contributing to a wide range of oral and
systemic diseases. My lab has been focusing on developing benchtop experimental tools to provide a
mechanistic framework of oral host-microbial interactions and modulation in early dysbiosis to support
therapeutic interventions. The bidirectionality of these interactions has been hypothesized to be attributed to
microbial metabolites, diet, immune, and endocrine factors. Specifically, sex as a biological variable has been
historically omitted from preclinical and clinical studies, resulting in a knowledge gap regarding how biological
systems respond to hormones and their fluctuations and, potentially, how therapeutic regimes can be tailored to
account for hormonal alterations. In particular, clinical studies have suggested that several microbiome-related
diseases display a sex bias, some of which have been shown to be associated with sex hormones. Specifically,
clinical evidence in common oral signs has been observed during menstruation, pregnancy, and hormonal
contraception use, however, mechanistic links between hormonal fluctuation, oral dysbiosis, and host tissue
health still need to be elucidated. Therefore, underscoring how sex hormone signaling affects disease
progression in the context of host-microbiome interactions is critical to support fundamental studies of disease
pathogenesis and to open the door to therapeutic strategies targeting both the microbiome, sex hormones and
the bidirectionality of those interactions. The mission of my research program is to address these fundamental
gaps in bidirectionality of host-microbiome cross-talks and underpinning the role of sex-bias in these interactions
and how it affects the onset and progression of inflammatory diseases, in a tractable in vitro model of the oral
mucosa. Over the next five years, I will expand the scientific knowledge over the following three themes of
research: (1) profiling human host tissue baseline as a function of sex difference and investigating tissue
responses to sex hormones changes, (2) underscoring the causal relationships between sex difference and
fluctuations of sex hormones and microbiome diversity and spatial organization, (3) dissecting the bidirectionality
of human host-microbiome interactions accounting for sex differences, hormonal changes under healthy and
inflamed clinically relevant conditions. The outcomes from this research program will provide insights into the
role of sex differences and hormonal fluctuations on human host-microbial interactions, opening the doors to
therapeutic approaches targeting both the microbiome, endocrine factors, and their mutual interactions.

Public health relevance
Project Narrative Sex as a biological variable has been historically omitted from preclinical and clinical studies, resulting in a knowledge gap regarding how biological systems respond to hormones and their fluctuations and, potentially, how therapeutic regimes can be tailored to account for hormonal alterations. Clinical studies have suggested that several microbiome-related diseases display a sex bias, some of which have been shown to be associated with sex hormones. The mission of my research program is to address these fundamental gaps in bidirectionality of host-microbiome cross-talks and underpinning the role of sex-bias in these interactions and how it affects the onset and progression of inflammatory diseases, in a tractable in vitro model of the oral mucosa.